Uncovering novel biological processes and pathogenic mechanisms for glaucoma

Project Summary/Abstract
Glaucoma is a leading cause of irreversible vision loss affecting 60 million people world-wide. Despite this,
prevention and treatment of glaucoma are limited. Primary open angle glaucoma (POAG), the most common form,
is characterized by progressive retinal ganglion cell death leading to optic neuropathy, often caused by elevated
intraocular pressure (IOP). The long-term goals of the proposed research are to identify genomic regions that
affect gene expression in glaucoma-relevant eye tissues, and in combination with large-scale human genetic
association studies, to uncover novel causal genes and key biological processes that can lead to glaucoma, which
may serve as effective drug targets for novel therapies. Genome-wide association studies (GWAS) have led to the
discovery of over 20 genomic loci associated with POAG and over 100 loci associated with IOP, however extracting
biological insights from these genetic associations has been challenging, largely due to the fact that the associated
variants lie in noncoding regions. Furthermore, much of the heritability of glaucoma has yet to be detected. The
Genotype-Tissue Expression (GTEx) project has shown that genetic variants associated with gene expression
variation (eQTLs) substantially contribute to disease risk, however GTEx does not contain data for ocular tissues.
The working hypothesis of the proposed research, supported by our preliminary results, is that hundreds of
regulatory effects will contribute to the pathogenicity of glaucoma and will explain much of its heritability, and
that the affected genes will cluster in disease-relevant biological processes. We thus propose in Aim 1, to create
a high-quality map of the transcriptome and open chromatin regions (indicative of transcriptional activity), and to
identify genetic variants associated with gene expression (eQTLs) and alternative splicing (sQTLs) in four key
pathogenic tissues for glaucoma: outflow pathway (trabecular meshwork and Schlemm’s canal), ciliary body,
optic nerve, and macular retina, collected from 100 postmortem donors. We will use RNA-seq, ATAC-seq, and
whole genome sequencing on bulk tissue and we will further identify cell type-specific eQTLs and sQTLs using
cell type-specific gene expression profiles from single cell RNA-seq studies that are available to us. In Aim 2, we
will apply novel computational and statistical methods that integrate data from Aim 1 with GWAS data of high or
normal-tension glaucoma and several risk factor traits, with the goal of identifying new genetic associations, and
the underlying causal genes, pathways, and pathogenic cell types for glaucoma. To broaden the impact of our
work, we will build a web-based platform for sharing, browsing, and inspecting gene expression and genetic
regulation data from the different eye tissues in relation to genetic associations with glaucoma and other complex
eye traits (Aim 3). The proposed research is expected to significantly improve our understanding of the
pathophysiology of glaucoma, uncover novel genetic risk factors, and open new avenues for therapeutic
development. Our genomics eye resource will also be valuable for studying the molecular causes of other eye
diseases, such as retinal degeneration diseases, and for tissue-targeted gene therapy design.

Public health relevance
Project Narrative Glaucoma is a leading cause of irreversible vision loss affecting 60 million people world-wide, however no effective primary prevention or treatment therapies exist for this blinding disease. While large-scale human genetic association studies have uncovered multiple genetic risk factors for glaucoma, the implicated genes and pathways are largely unknown. The goals of the proposed research are to characterize gene expression and its genetic regulation in glaucoma-relevant tissues from healthy human eyes, and to use this information together with human genetics studies to discover novel biological processes and pathogenic mechanisms for high- and normal-tension glaucoma.